Insights into infection of Ilheus virus in mammalian and mosquito cells

SUMMARY
Global health is perpetually challenged by emerging and reemerging infectious diseases. In recent times climate
change and globalization has contributed to the rampant spread of mosquitos from tropical and subtropical
climates into more moderate climates, and thus also the spread of one of the most important mosquito-borne
viruses namely flaviviruses. These viruses can cause asymptomatic, mild infection as well as severe disease
such as encephalitis and death. Thus, understanding the foundational molecular virology, virus-host interactions,
transmission, and pathogenesis is critical to limiting the disease burden of flaviviruses, especially as licensed
antivirals and vaccines are limited. In this application we propose to investigate Ilheus virus (ILHV), an
understudied mosquito-borne flavivirus with the potential to emerge. ILHV cause disease in humans, and in
different animal and bird species. The virus has primarily been isolated from Culex, Aedes and Psorophora
mosquitoes. To date, the following types of studies on ILHV have been conducted: surveillance and serological
studies of ILHV in the Americas, sequence analysis of the different isolates, crystal structure of the ILHV NS3
protein, a cross protection study for the related Rocio virus, and anti-ILHV effects of caffeic acid. There is however
no research investigating the kinetics of ILHV infection in mammalian and mosquito cells, nor the availability of
an infectious clone that would permit manipulation of the viral genome for mechanistic studies. Given that the
R03 Small Research Grant program is directed towards early and feasibility projects, research projects with
limited scope or generation of new methods and tools, we propose that our application is ideally suited to this
funding mechanism. In Aim 1, we will examine ILHV infection in different mammalian, bird, and mosquito cell
lines, as well as primary skin and monocyte cultures. We will also examine the activation of the innate immune
response and expression of select interferon stimulated genes. In Aim 2, we intend to construct an infectious
clone and subgenomic nanoluciferase reporter replicon. Flaviviruses use complementary sequences in the 5’
and 3’ untranslated regions of the RNA genome to facilitate cyclization, a step that is critical for virus replication.
We will use the infectious clone and subgenomic replicons to characterize the putative cyclization sequences in
the ILHV RNA (Aim 2). Completing these Aims will establish the groundwork for important future studies
investigating the structure of the ILHV RNA genome, virus-host interactions and vector competence studies that
could impact the identification and developments of new antiviral treatment options.

Public health relevance
NARRATIVE Ilheus virus (ILHV) is an understudied mosquito-transmitted flavivirus that has the potential to emerge and cause significant disease in the human population. This research will generate foundational knowledge on ILHV infection that will direct future virus-host interaction, pathogenesis, and transmission studies to ultimately impact the development of effective treatment strategies for ILHV.